DOX-SL IN THE TREATMENT OF MODERATE TO SEVERE AIDS RELATED KAPOSI'S SARCOMA

This protocol will study patients with Kaposi's sarcoma (KS) who have no remaining treatment options other than Stealth Liposomal Doxorubicin HC1 (DOX-SL) or those who have participated in another DOX-SL protocol and for whom continuation on SOX-SL is medically indicated. The study will evaluate the safety and efficacy of DOX-SL in KS patients who have previously received systemic chemotherapy with or without an anthracycline.